West Virginia University Stroke COBRE

Project summary/Abstract
Stroke is the fifth leading cause of death and the leading cause of disability among Americans
and developing effective treatments for stroke remains a pressing need. The Experimental Stroke
Core (ESC) is an essential core for the West Virginia University (WVU) Stroke CoBRE that
provides unique expertise and develops novel tools and stroke animal models to enhance the
effectiveness of stroke researchers. The overall goal for the ESC is to provide the expertise,
training, instrumentation, and resources for the incorporation of animal models of stroke into the
research of junior investigators participating in the WVU Stroke CoBRE and researchers in the
greater WVU neuroscience and cardiovascular research community. The four proposed specific
aims of the ESC will help advance the WVU Stroke CoBRE to a Center of Excellence and,
thereby, achieve sustainability after CoBRE funding ends. Aim 1: To provide the expertise,
instrumentation and resources to produce strokes in rodent models. Aim 2: To provide processes
by which users can access the ESC expertise and resources. Aim 3: To provide mentoring and
training in experimental stroke research. Aim 4: To develop new animal models and implement a
sustainability business plan for the Experimental Stroke Core. Achieving these specific aims will
provide a highly functioning ESC for the research community and bridge a transition of CoBRE-
supported-ESC to an independent core facility.